Academic Science Education and Research Training

ABSTRACT
The New Mexico Academic Science Education and Research Training (ASERT) Institutional Research and
Career Development Award (IRACDA) consortium recruits, trains, and develops a diverse cadre of postdoctoral
scholars. The University of New Mexico – a Hispanic and Minority Serving Institution (MSI) – serves as the lead
research-intensive institution in partnership with three accredited, teaching intensive, MSIs – Central New Mexico
College, Southwestern Indian Polytechnic Institute and New Mexico State University. The ASERT program offers
rigorous, interdisciplinary research training with 68 research mentors and co-mentors who have expertise in
biomedicine that includes perspectives from biology, biological anthropology, chemistry, computational and
physical sciences, biological engineering, learning sciences, pharmaceutical sciences, and social sciences.
Importantly, ASERT also affords exceptional training opportunities in education pedagogy and immersive,
practical teaching experiences. Central New Mexico College and Southwestern Indian Polytechnic Institute (a
national Tribal College) serve minority, lower income, and American Indian undergraduate students, respectively.
CNM and SIPI have student centered programming and offer Associate level degrees in science, technology,
engineering, mathematics, including physical, environmental and health sciences, among other disciplines.
Agreements with 4-year colleges and universities statewide enable fast-track pathways and transfers to
combined bachelors and graduate degree programs. New Mexico State University is a land grant R2 research
university offering undergraduate and graduate degrees. All partnered institutions have a diverse faculty, value
education excellence, inclusion of cultural perspectives, and have deep commitments to developing a diverse
workforce founded on justice, equity, diversity, accessibility, and inclusion (JEDAI) principles. In partnership with
these three MSIs, fellows can elect to work with education mentors who have undergraduate to graduate level
teaching expertise and discipline relevant knowledge. On average 12 fellows constitute a training cohort and are
supported in their professional development and advancement of career goals by the ASERT program for up to
three years. Formal courses, individual development plans evaluated by faculty mentoring teams, monthly cohort
meetings, annual retreats and professional development workshop series contribute to skill building and rigor in
science and education. Fourth to fifth years are supported by mentors when beneficial for individual fellow's
career goals. Since 2009, 52 ASERT alumni have assumed productive academic research/teaching or private
sector biomedical careers in NM, the Southwest Region and the Nation. Annual program evaluation and
outcomes assessment is conducted by faculty expert in evaluation and learning sciences. Identified strengths
and areas for growth are incorporated into the proposed renewal plan. In sum, the New Mexico ASERT fellowship
program has twice hosted the national network meeting in Albuquerque, NM and is a pivotal member of the
national IRACDA network affording trainees with unique research, teaching, and role model opportunities.

Public health relevance
Narrative The New Mexico Academic Science Education and Research Training K12 IRACDA Program prepares postdoctoral fellows to excel in all facets of academic life at institutions likely to have highly diverse student populations. Training is achieved through: (1) conduct of cutting-edge research with scientists at the University of New Mexico, (2) career development and skill-building activities, and (3) practical teaching experiences at one of three partnered Minority Serving Institutions in New Mexico. Ninety-eight percent of ASERT alumni are in biomedical research or education positions, where they make new discoveries and technological advances, improve healthcare, innovate teaching strategies, and motivate the next generation of students in research.